Addressing COVID 19 Vaccine Hesitancy in Rural Community Pharmacies Reducing Disparities Through an Implementation Science Approach

PROJECT SUMMARY
The COVID-19 pandemic has disproportionally impacted rural communities, which are often health
professional shortage areas that lack health care infrastructure, including hospitals1-3. When compared to
urban populations, individuals living in rural areas are more vaccine hesitant8,9, have a higher prevalence of
comorbid health conditions that increase their risk for severe COVID-19 complications12, and are at greater risk
from SARS-CoV-2 variants due to lower vaccination rates and fewer vaccination mandates33,40. Thus,
interventions to increase vaccine uptake in rural areas are greatly needed. As the most accessible healthcare
professional in rural areas4,5 and one of the most trusted sources of medication information16, community
pharmacists are well-positioned to address vaccine hesitancy with underserved, rural populations.
Because vaccination conversations are sensitive and often politically charged, pharmacists need
implementation support, including training and ongoing guidance to deliver evidence-based vaccine
hesitancy counseling interventions18. Implementation facilitation, in which trained facilitators coach and
troubleshoot problems with professionals as they implement new practices, increases adoption of practices
with fidelity23-26. However, implementation facilitation generally, and virtual facilitation (e.g., video coaching) in
particular, has not been systematically studied in community pharmacy settings. The need to examine the
effectiveness of virtual facilitation as a means to increase vaccine hesitancy counseling and COVID-19
vaccination is of great importance given the large travel distances to rural areas and social distancing.
Our goal is to test if virtual facilitation increases rural pharmacists’ ability to implement COVID-19 vaccine
hesitancy counseling when compared to a “standard” implementation approach (e.g., training and
dissemination of implementation support tools). Using a rural pharmacy practice-based research network
(PBRN) that spans 5 southeastern states, we propose two aims. Aim 1 involves a stepped-wedge trial with 30
rural pharmacies to test whether virtual facilitation outperforms the standard approach in increasing: (a) the
fidelity with which pharmacists implement the vaccine hesitancy counseling intervention and (b) the number of
vaccine hesitant patients who agree to receive the vaccine. Using a project-sponsored data collection system,
we will gather data on implementation outcomes, including fidelity and effectiveness. In Aim 2, we will conduct
a cost assessment to explore the sustainability of virtual facilitation. We are uniquely positioned to test these
competing implementation approaches and leverage rural community pharmacists to engage in vaccine
hesitancy counseling in rural communities that have low vaccination rates.

Public health relevance
PROJECT NARRATIVE COVID-19 vaccine hesitancy is higher among rural populations, who have some of the lowest COVID-19 vaccination rates in the nation. Community pharmacists, who are the one of the most trusted and accessible health professionals in rural areas, are well-positioned to provide COVID-19 vaccinations and address vaccine hesitancy in their communities. This project will examine sustainable ways to support rural pharmacists as they implement COVID-19 vaccine hesitancy counseling practices to mitigate the negative impact of COVID-19 and SARS-CoV-2 variants in underserved rural populations.